Task B1: Phase I Clinical Trial to Evaluate a Therapeutic for Antibiotic Resistant Infections

The Phase I Clinical Trial Units provide a vehicle for the investigation of new therapeutic and immunomodulatory agents for the treatment of infectious disease.